Southeastern Pennsylvania Adult and Pediatric Prevention Epicenter Network

Project Summary
Healthcare-associated infections (HAIs) and antibiotic resistance (AR) are leading causes of morbidity and
mortality worldwide. Concerted efforts are required to define the epidemiology and impact of emerging HAI and
AR issues, as well as identify and test novel strategies to address these urgent problems. The CDC Prevention
Epicenter site at the University of Pennsylvania and the Children’s Hospital of Philadelphia (i.e., the Penn-
CHOP Epicenter) has been engaged in numerous initiatives focused on HAIs and AR. The considerable
research support and infrastructure provided by the CDC’s Prevention Epicenters Program has served to
facilitate significant scientific achievements demonstrated in part by 71 peer-reviewed publications and 110
scientific abstracts from the Penn-CHOP Epicenter group since site inception in 2011. The Penn-CHOP
Epicenter has also provided a rich scientific environment within which investigators with complementary areas
of expertise collaborate to address the most urgent issues in HAI and AR. Finally, the Penn-CHOP group has
collaborated extensively with other CDC Epicenter sites and healthcare networks to answer critical scientific
questions. The projects proposed in this application build on the strong foundation established by prior work
from the Penn-CHOP investigators. These studies focus on acute, post-acute, and outpatient care settings and
include adult and pediatric populations. Finally, these projects include collaborations with other sites, health
care networks, public health agencies, and regional partnerships.
This application is comprised of 6 Core Projects and 3 Optional Collaborative Projects:
CORE PROJECTS
Core Project #1: Screening and Targeted Prophylaxis for Clostridioides difficile Infection (CDI) among
Immunocompromised Hosts (SToP-CDI)
Core Project #2: Non-residential Exposures to Multidrug-Resistant Organisms (NEXUS)
Core Project #3: Reducing Antimicrobial Prescribing in Dialysis (RAPID)
Core Project #4: Microbiome Sampling in Pediatric Post-Acute Care to Understand Multidrug-resistant
Organism Risk, Antibiotic Effect, and Ventilator-associated Infection (MS PAC-MAN)
Core Project #5: Natural Language Processing for Antibiotic Prescribing in Sinusitis (NAPS)
Core Project #6: Antibiotic Stewardship for Ambulatory Surgery Prophylaxis (ASSURE)
OPTIONAL COLLABORATIVE PROJECTS
Small Collaborative Project: Communication And Coaching To Increase Steward Influence (CACTIS)
Medium Collaborative Project: Reducing Vancomycin Administration in Pediatric Sepsis (REVAMP-Sepsis)
Large Collaborative Project: Fecal Microbiota Transplantation to Address Colonization and Environmental
Contamination with Multidrug-Resistant Organisms (FACE-MDRO)

Public health relevance
Project Narrative Healthcare-associated infections (HAIs) and antibiotic resistance (AR) are leading causes of morbidity and mortality worldwide. The studies proposed in this application seek to build on the considerable track record of the Penn-CHOP CDC Prevention Epicenter by further elucidating the epidemiology and impact of HAIs and AR as well as identifying and testing novel strategies to address these urgent problems.